Developmental Funds

DEVELOPMENTAL FUNDS – PROJECT SUMMARY/ABSTRACT
The Cold Spring Harbor Laboratory (CSHL) Cancer Center is marked by creative and energetic faculty,
innovative and collaborative research, and an emphasis on developing technologies that are used broadly in
cancer research labs around the world. Cancer Center Developmental Funds have provided critical seed funding
to strategically recruit six new faculty, stimulated collaboration and interdisciplinary science through twelve pilot
projects, and spurred innovation through the Shared Resources in eight technology-development projects. With
the support of the Executive Committee and Senior Leadership, the Cancer Center Director utilized these funds
to implement the Center’s strategic initiatives. When paired with substantial Institutional support and
philanthropic funding, these Developmental Funds resulted in significant returns on investment, including 48
published papers and preprints and nine additional papers in preparation or under review. In addition, funding
for new investigators led to data that supported the successful application for more than $5.7 million in peer-
reviewed external funding and a total of 25 successfully funded external grants over the last five years. As a
whole, Developmental Funds are an extremely valuable source of support that enables the CSHL Cancer Center
to make fundamental discoveries about the biological mechanisms underlying cancer and to develop unique
approaches towards the diagnosis, treatment, and prevention of cancer.

Public health relevance
DEVELOPMENTAL FUNDS- PROJECT NARRATIVE Not required per PAR-20-043